Cell and Tissue Imaging (CTI)

PROJECT SUMMARY/ABSTRACT (CELL AND TISSUE IMAGING SHARED RESOURCE)
The Cell and Tissue Imaging Shared Resource (CTI-SR), was established as an institutional core at U-M in
1978, approved by the NCI in 1991, and became a Rogel Cancer Center (Rogel) facility in 1995. The CTI-SR is
a centralized, shared instrumentation resource with advanced microscopy and imaging technologies that are
vital to studying cell and tissue morphology and ultrastructure. As such, the facility provides a cost-effective
solution for Rogel researchers to utilize state-of-the-art imaging instrumentation with the technical support
necessary to succeed in both routine and advanced imaging modalities from inception to publication. In addition
to offering instrument time, CTI-SR offers routine and advanced services in electron microscopy sample
processing, sectioning, staining, and analysis. The availability of highly trained personnel with years of expertise
is a distinct advantage to Rogel members, as is the Rogel member subsidy. The facility also emphasizes training
to ensure that all users operate the advanced equipment properly, independent of prior experience.